F31 Microtubule function in the onset of whole-body regeneration

Project Summary
Tissue regeneration is the process of renewal, restoration and growth that allows an organism to re-grow
limbs and organs after injury. Tissue regeneration abilities are present in diverse organisms, suggesting they
may have been ancient, so the mechanisms controlling regeneration have been important to understand. The
freshwater planarian flatworm Schmidtea mediterranea regenerates from nearly any surgical injury, including
decapitation, and is a model for understanding the mechanistic basis of animal regeneration. After injury, tissue
near wound sites signals to nearby adult pluripotent stem cells called neoblasts, which differentiate to replace all
cell types of missing tissue. The highly conserved Wnt signaling pathway is essential for controlling regeneration
of anterior-versus-posterior tissue identity in planarian regeneration. The earliest event in head versus tail
determination is the injury induced expression of the secreted Wnt inhibitor notum selectively at anterior-facing
and not posterior-facing wound sites. However, the mechanism directing this symmetry breaking event is
unknown. Injury induced notum expression occurs from the soma of body wall muscle cells possessing
longitudinally aligned muscle fibers, suggesting a role of muscle cell orientation and polarity in the onset of
regeneration. However, the molecular signals and structure regulating this polarity are unknown, but classic
small molecule inhibition studies in planaria suggest a possible role for microtubules in this process. The goal of
this project is to uncover the mechanisms by which microtubules participate in the polarity of the regeneration
response in the following specific aims. Aim 1 utilizes RNAi to test roles for microtubule regulatory factors
expressed in muscle to control injury-induced gene expression at the onset of tissue regeneration. Aim 2 uses
epistasis analysis with RNAi to uncover the mechanism by which a kinesin microtubule motor protein relates to
a Wnt pathway for head and eye regionalization used in regeneration. These experiments will provide insight on
the cellular and molecular mechanism of microtubules during injury induced regeneration. My results will provide
new insights into understanding the other factors necessary for proper injury signal and help form a better
understanding on what regulates polarity.

Public health relevance
Project Narrative Mammals after injury will not be able to replace the missing tissue with new identical tissue but will form a scar which losses some of its functionality compared to the original tissue. This project will investigate how early injured induced signals and patterning during regeneration is regulated by microtubules. These studies are important in determining the how microtubules initiate regeneration, how motor proteins regulate patterning genes and could implicate roles novel roles of microtubules human regeneration.